Vertebrate Sex Determination 2023

Project Summary
This application is to request funds to provide partial support for the 9th International Symposium on the Biology
of Vertebrate Sex Determination in April of 2023. This symposium has been held at 3-year intervals since its
inception in 1997. Due to the pandemic, the originally scheduled symposium in 2021 was postponed to 2023.
This unique symposium is attended by the entire international field working on sex determination in diverse
vertebrate systems, such as amphibians, fishes, birds, reptiles, monotreme, marsupial, and eutherian mammals,
including domesticated species, mice, and humans. It is nearly impossible to keep up with the advances made
in so many diverse vertebrate systems. Therefore, the objective of this symposium is to bring the community
together so that junior and senior scientists can exchange information, using a comparative approach to advance
our understanding of the process of sex determination, sex differentiation, disorders and differences of sex
development, and environmental impacts on this process. The first eight symposia yielded many collaborations:
reagents were exchanged, experiments planned, and new ways of investigating sex determination discussed.
The last symposium in 2018 attracted many junior scientists (~70% of the participants), including graduate
students, postdoctoral fellows, and assistant professors. We propose to continue and enhance this tradition by
including trainees and junior faculty on the organization committee and empowering them to organize activities
beneficial to their careers. We also emphasize on enhancing diversity and creating a harassment-free
conference environment. We expect the 9th Symposium to be as productive and stimulating as the previousones
and will bring the scientific community together after a 5-year hiatus.

Public health relevance
Project Narrative Sexual development during embryogenesis leads to the formation of the reproductive organs that define the morphology and physiology of males and females. Genetic and environmentally induced birth defects in sexual development result in clinically significant abnormalities that include intersex, common genital abnormalities such as hypospadias, infertility, and pathologies such as cancer. The proposed conference will bring together senior and junior scientists from around the world who are studying these processes in different types of vertebrate animals to share the most recent findings in the field, apply new knowledge to the understanding and treatment of disorders/differences of sex development and diseases, foster career development of junior scientists, and enhance diversity in this scientific community.